Minnesota Precision Medicine CKD & Resilient Diabetes Recruiting Site: Engagement, Enrollment & Ethics

PROJECT SUMMARY
Chronic kidney disease (CKD) is an important health problem associated with high morbidity and mortality.
Unraveling the mechanisms associated with risk of or protection from CKD will significantly advance a precision-
medicine approach to CKD prevention, diagnosis, and treatment.
The Minnesota-KPMP (Minn-KPMP) will ethically and safely obtain research kidney biopsies, biosamples, and
data from well phenotyped participants with CKD due to diabetes or hypertension and from patients with no
clinical manifestations of CKD despite decades of type 1 diabetes (T1D). In a highly diverse metropolitan area
actively confronting racism and disparities, Minn-KPMP will engage a diverse patient population to evaluate and
address barriers to enrollment in KPMP and to elicit the perspectives of our local participants on ethical issues
posed by the KPMP, such as return of results and biobank governance. This will add significantly to KPMP
community engagement and ethics.
Leveraging the Biomedical Informatics and Data Access service of the University of Minnesota Clinical and
Translational Science Institute (CTSI) Best Practices Integrated Informatics Core (BPIC), we will interrogate the
large MHealth Fairview (MHealth) database to identify, recruit, enroll, and obtain clinical data, biosamples, and
kidney biopsies from patients with CKD-Diabetes and CKD-Hypertension and resilient-T1D. We will work closely
with KPMP and help to refine and follow common study protocols while following maximum safety precautions.
The long-standing successful track record of our group in recruiting patients into clinical trials of CKD, and our
ethically rigorous approach to consenting for kidney biopsy and strict adherence to KPMP safety measures will
ensure our meaningful contribution to the KPMP mission and goals.
Minn-KPMP has assembled an outstanding team of investigators and consultants to recruit and follow
participants with CKD and with resilient T1D (Res-T1D). Directly relevant to this application, the Minn-KPMP
study team has a long-standing track record of successfully recruiting, following-up, and safely and ethically
performing research kidney biopsies, including sequential kidney biopsies, in a wide range of participants,
including participants with diabetes and with no clinical manifestations of CKD, siblings with diabetes, kidney
donors, kidney transplant recipients, and pancreas transplant recipients. Obtaining high quality biosamples,
including kidney biopsy samples, from well phenotyped study participants is key to KPMP success, so that these
tissues can be used for transcriptomic, proteomic, and metabolomic analyses. The Minn-KPMP is eager and
fully prepared to collaborate with the other KPMP recruiting sites, tissue interrogation sites, central hub, steering
committee, DSMB, external expert panel, and the almost 300 members of the KPMP.

Public health relevance
PROJECT NARRATIVE The Minnesota-KPMP will recruit and follow-up study participants with chronic kidney disease due to diabetes or hypertension, the most common causes of chronic kidney disease, plus participants with type 1 diabetes who do not have clinical manifestations of kidney disease despite long diabetes duration. Underserved and underrepresented populations are disproportionately affected by chronic kidney disease, and the Minnesota- KPMP will engage a diverse patient population to evaluate and address barriers to enrollment in KPMP and to elicit the perspectives of our local participants on ethical issues posed by the KPMP, such as return of results and biobank governance. In a highly diverse metropolitan area actively confronting racism and disparities, this will add significantly to KPMP community engagement and ethics.